Core 3 Non Human Primate Studies

Radiation Countermeasures Center of Research Excellence
Core 3: Primate Studies
Abstract
The Primate Studies Core facilitates the conduct of late-stage preclinical studies of mitigators of
radiation damage in nonhuman primates (NHP), following the specific priorities of the RadCCORE
consortium and sharing tissue and data with other CMCRs nationwide. Because of the high degree of
genetic and physiologic similarity of nonhuman primates to human beings, this resource is a critical
component of translational assessment of candidate deliverable agents, in an experimental setting
under which relevant doses of whole-body irradiation can be given to healthy subjects. Core
investigators have unique skills in the experimental use and clinical medicine of nonhuman primates,
including irradiation, veterinary medical care and management of myelosuppressed animals,
comparative pathology of primates, pathology of radiation injury, biochemistry, clinical pathology and
endocrinology of primates, and adaptation of molecular biologic techniques to the primate model. Core
services include study planning, regulatory approvals, acquisition and maintenance of specific-
pathogen-free nonhuman primates, exposure of animals to radiation, administration of therapeutic
interventions, and clinical and pathologic assessments of treatment outcomes, including
necropsy/tissue collection and sharing for baseline characterization of radiation responses and
assessment of mitigating interventions. The Core also provides extensive data management services
for primate studies, including data sharing and interaction with the biostatistics core to facilitate analysis
and publication of findings. The main core user for the proposed funding period will be Project 3, FSL-1
as a GI and hematopoietic mitigator, but all Projects will be served, through sharing of tissues, fluids
and data; design and review of plans for future prospective studies.

Public health relevance
Radiation Countermeasures Center of Research Excellence Core 3: Primate Studies Narrative The Primate Studies Core facilitates the conduct of late-stage preclinical studies of mitigators of radiation damage in nonhuman primates (NHP), following the specific priorities of the RadCCORE consortium and sharing tissue and data with other CMCRs nationwide. Core investigators have substantial experience and expertise studying radiation countermeasures in NHPs. The main core user will be Project 3, FSL-1 as a GI and hematopoietic mitigator, but all Projects will be served.